A DNA BANK FOR CLINICAL RESEARCH SUBJECTS

The purpose (specific aim) of this study is to isolate DNA from human subjects who participate in metabolism protocols of the PI for genetic markers of salt sensitivity of blood pressure and insulin resistance.